Project 1:Improving Pancreatic Risk Assessment

Project Summary/Abstract:
Our overall foundation is that there are identifiable genetic predispositions to the development of pancreatic
cancer. Our prior work has established the importance of inherited factors in the development of pancreatic
cancer, and identified BRCA2, PALB2 and ATM as familial pancreatic cancer genes. However, the familial
clustering is still unexplained for 80% of pancreatic cancer families. This leads to our overall translational
goals; to increase our scientific evidence base to inform genetic counseling and risk assessment of at-risk
individuals by identifying new pancreatic cancer genes and to identify people at high-risk who would benefit
most from future chemoprevention trials and efforts to screen for early, and therefore potentially curable,
pancreatic neoplasia. As part of this project we will 1A) To determine the contribution of germline structural
variants to pancreatic cancer susceptibility; 1B) To identify novel pancreatic cancer susceptibility genes
through a combined analysis of single nucleotide variants and structural variants: 2) To evaluate and
characterize candidate pancreatic cancer susceptibility genes; 3A) To determine if personal or family histories
of cancers other than pancreatic cancer can be used to better estimate the risk of developing pancreatic
cancer 3B) to develop and validate an enhanced and clinically practical pancreatic cancer risk
stratification model incorporating risk factors identified in Aims 1, 2 and 3A.
In summary, through this project we hope to continue to unravel the genetic basis of inherited pancreatic
cancer and develop practical, robust and clinically relevant tools to guide precision risk-management strategies
for these families.

Public health relevance
Project Narrative: The goal of this project is to identify new familial pancreatic cancer genes, quantify the risk of pancreatic cancer associated with these new genes and to use these findings to improve risk modeling for pancreatic cancer.